High-content screening for TPI Deficiency therapeutics

Abstract/Project summary:
TPI Df is a devastating untreatable childhood metabolic disease resulting in anemia,
paralysis, irreversible brain damage and premature death. Numerous subtle amino acid
substitutions in Triosephosphate Isomerase (TPI) are pathogenic and result in rapidly
progressing multisystem disease. Importantly, all known pathogenic TPI Df mutations result
in a protein that retains function and pathogenesis is known to result from increased
turnover of the functioning protein by Protein Quality Control pathways (PQC). We have
developed a human cellular TPI Df assay based on a cellular model of the “common” E104D
mutation and implemented it for high-content, high-throughput imaging. We have used this
model in a pilot screen and validated its utility to identify novel compounds that modulate
mutant TPI protein levels in human cells. We have developed the assay to full HTS
standards, and propose to screen the 225,000 member NIH MLSMR compound library to
identify hit-to-lead compounds to develop into TPI Df small molecule therapies. We will
validate hits in secondary assays for TPI stability and activity in TPI Df patient cells, prioritize
them in a panel of in vitro toxicology and metabolism assays, examine structure activity
relationships (SARs) of the lead compounds and substantially validate them in vivo using
established Drosophila and mouse models that reflect the entire range of TPI Df disease
severities. Overall, this project will discover initial therapies for development and test
efficacy of our lead compounds in TPI Df models, including a newly validated mouse model.

Public health relevance
Narrative: TPI Df is an untreatable metabolic disease. Although disease pathogenesis is known to result from inappropriate targeting of functional mutant protein for degradation, drug therapies do not exist for this disease. We have developed an optical cellular assay for compounds that stabilize mutant TPI, and will use the platform to screen a diversity compound library and identify starting points for development into the first in class TPI Df small molecule therapies. We will prioritize molecules using toxicology and metabolism assays, and validate the most promising compounds in TPI Df patient cells and in vivo using established Drosophila and mouse models. Overall, this project will discover initial therapies for development and test efficacy of our lead compounds in TPI Df models, including a newly validated mouse model.